Advancing Rehabilitation Paradigms for Older Adults in Skilled Nursing Facilities

PROJECT SUMMARY/ABSTRACT
This Diversity Supplement research supplements the larger i-STRONGER initiative, which investigates the
effectiveness of a high-intensity rehabilitation intervention in Skilled Nursing Facilities (SNFs). Anticipating
variable clinician implementation across multiple SNFs due to pilot results and the involvement of 120
clinicians, this supplementary project employs innovative quantitative methods to comprehensively evaluate
both facility and clinician factors influencing i-STRONGER implementation. Aim 1 focuses on facility factors,
utilizing multilevel linear regression to assess the impact of leadership strength, staffing ratios, and overall
facility culture on clinician implementation. Aim 2 delves into clinician factors, employing multilevel linear
regression to analyze demographics, clinical experience, leadership roles, self-efficacy, and perceived barriers.
Innovatively departing from prior qualitative approaches, this project aligns factors with the Theoretical
Domains Framework for translation of results into actionable behavior change techniques. Dr. Frannie
Westlake will receive mentoring from Dr. Jennifer Stevens-Lapsley and Dr. Jeri Forster for rehabilitation
research and biostatistics respectively. Dr. Westlake's career development plan aims to address research skill
gaps through biostatistics training, clinical outcomes education, dissemination and implementation research,
and overall professional development. This research project, with its comprehensive approach and innovative
methods, is poised to significantly impact the understanding of clinician implementation factors, providing
valuable insights for the optimization of future healthcare interventions in SNFs, while providing a rich training
experience for Dr. Westlake. The comprehensive career development plan is strategically aligned with Dr.
Westlake's overarching goal of contributing significantly to health-related research. The mentorship team will
provide the necessary guidance and support to ensure Dr. Westlake's success as she advances in her journey
towards becoming an independent investigator and influential figure in rehabilitation research.

Public health relevance
PROJECT NARRATIVE This diversity supplement aims to explore clinician and facility factors that influence implementation of a high- intensity rehabilitation intervention in skilled nursing facilities. The candidate will be guided by mentors in rehabilitation research and biostatistics to implement the proposed research. The mentorship team will provide the necessary guidance and support to ensure the candidate's success as she progresses towards establishing herself as an independent investigator and a prominent figure in the field of rehabilitation research.